Shaping the Microenvironment by DPEP1 Facilitates Adenoma Progression

PROJECT SUMMARY/ABSTRACT
Project 1: Shaping the Microenvironment by DPEP1 Facilitates Adenoma Progression
Project 1 aims to examine how shaping the microenvironment by DPEP1 facilitates adenoma progression. This
will be a basic project. We propose that dipeptidase-1 (DPEP1) marks those adenomas with the potential to
progress to colorectal cancer (CRC) through an active bi-directional communication with neutrophils. DPEP1
has two functions: dipeptidase activity and recently identified neutrophil-binding activity. Our hypothesis is that
DPEP1, largely through its neutrophil-binding activity, marks adenomas with a predilection for progression. We
have found that DPEP1 immunoreactivity is detected in 27% of colorectal adenomas but this increases to 72%
of CRCs, consistent with DPEP1 marking the small subset of adenomas that progress to CRC. Utilizing human
specimens, a unique Transwell co-culture system of adenoma organoids and freshly isolated neutrophils isolated
from healthy volunteers, and an informative mouse model, we will test if DPEP1-expressing adenomas more
effectively communicate with neutrophils and create a neutrophil-enriched microenvironment, increasing the
likelihood that these adenomas will progress. Exosomes have attracted a great deal of recent attention as a rich
source of cargo that may serve as cancer biomarkers. We have found that DPEP1 is released in exosomes from
CRC cell lines and that it highly enriched in a subset of exosomes that contain known CRC biomarkers, CEA
and EPCAM. Of interest, neutrophils also release small extracellular vesicles (sEVs) that contain neutrophil
elastase in a form that cannot be inhibited by elastase inhibitors, and thus it is especially potent in degrading the
extracellular matrix, a key step in cancer invasion. We will also use a unique neutrophil reporter mouse to monitor
onset and perdurance of neutrophil infiltration, along with the properties of these neutrophils, in an inducible,
stem cell-driven mouse model of colonic adenomas.
.